Acquisition of a dedicated and integrated HD-MS instrument

Project Summary
This funding application aims to acquire a state-of-the-art, integrated mass spectrometry-based
system for hydrogen/deuterium exchange (HDX-MS) studies on complex protein systems. The
system will support a large community of biomedical researchers at Case Western Reserve
University and neighboring institutions, including the Cleveland Clinic Learner Research Institute,
University Hospitals, the Veteran Affairs Hospital, the MetroHealth Rammelkamp Center for
Education and Research, and Cleveland State University. Currently, we have eight main users
and nine minor users, with six already utilizing or recently using HDX-MS for their projects.
However, the existing equipment, now over 15 years old, is outdated and does not facilitate
efficient, sensitive, or reliable experiments compared to the proposed instrument. Remarkably,
there is no state-of-the-art HDX-MS equipment dedicated to hydrogen/deuterium exchange
studies in the entire Greater Cleveland area or even in Ohio. The HDX-MS approach is vital for
characterizing highly complex and challenging systems, including large protein-protein complexes,
protein aggregates associated with neurodegenerative disorders, membrane channels,
membrane-associated proteins, and protein-nucleic acid complexes. This technology will be an
invaluable tool for structural biology research, benefiting numerous NIH-funded investigators
working on fundamental biological and biomedical problems. It will expand the scope of
biomedical research and foster collaborative interactions. More than 30 NIH-funded research
projects will immediately benefit from this instrument. These include studies on misfolded protein
aggregates, protein-protein complexes involved in cell signaling, self-assembling proteins in
synaptic vesicle endocytosis, GPCRs, large multimeric membrane channels (ligand-gated
channels, aquaporin channels), membrane and water-soluble receptors, and inflammasome
signaling complexes. These projects contribute to a better understanding of the pathogenic
processes associated with these systems. Moreover, the insights gained will aid in developing
novel therapeutic strategies for various diseases, including neurodegenerative disorders, cancer,
cardiovascular diseases, pain, visual impairment, bacterial and viral infections, and inflammation.

Public health relevance
Project Narrative The purpose of this application is to establish a state-of-the-art facility in the Greater Cleveland/Northeast Ohio area dedicated to studying the structure and dynamics of complex biomolecular systems using hydrogen/deuterium exchange coupled with mass spectrometry. This facility aims to support numerous NIH-funded projects focused on a wide range of diseases of significant public health importance.